Temporal relation discovery for clinical text

? DESCRIPTION (provided by applicant): The overarching long-term vision of our research is to create novel technologies for processing clinical free text. We will build upon the previous work of our ongoing project Temporal relation discovery for clinical text (R01LM010090) dubbed Temporal Histories of Your Medical Events (THYME; thyme.healthnlp.org) which has been focusing on methodology for event, temporal expressions and temporal relations discovery from the clinical text residing in the Electronic Health Records (EHR). We developed a comprehensive approach to temporality in the clinical text and innovated in computable temporal representations, methods for temporal relation discovery and their evaluation, rendering temporality to end users - resulting in over 35+ papers and presentations. Our dissemination is international and far-reaching as the best performing methods are released open source as part of the Apache Clinical Text Analysis and Knowledge Extraction System (ctakes.apache.org). The methods we developed are now being used in such nation-wide initiatives as the Electronic Medical Records and Genomics (eMERGE), Pharmacogenomics Network (PGRN), Informatics for Integrating the Biology and the Bedside (i2b2), Patient Centered Outcomes Research Institute and National Cancer Institute's Informatics Technology for Cancer Research (ITCR). Through our participation in organizing major international bakeoffs - CLEF/ShARe 2014, SemEval 2014 Analysis of Clinical Text Task 7, SemEval 2015 Analysis of Clinical Text Task 14, SemEval 2015 Clinical TempEval Task 6 - we further disseminated the THYME resources and challenged the international research community to explore new solutions to the unsolved temporality task. Through all these activities it became clear that computational approaches to temporality still present great challenges and usability of the output is still limited. Therefore, we propose to further innovate on methodologies and end user experience. Specific Aim 1: Extract enhanced representations and novel features to support deriving timeline information. Specific Aim 2: Develop methods to amalgamate individual patient episode timelines into an aggregate patient-level timeline. Specific Aim 3: Mine the EHR - the unstructured clinical text and the structured codified information - for full patient-level temporality. Specific Aim 4: Develop a comprehensive temporal visualization tool Specific Aim 5: Develop methodology for and perform extrinsic evaluation on specific use case. Specific Aim 6: (1) Evaluate state-of-the-art of temporal relations through organizing international challenges under the auspices of SemEval, (2) Disseminate the results through publications, presentations, and open source code in Apache cTAKES. Functional testing.

Public health relevance
Project Narrative Temporal relations are of prime importance in biomedicine as they are intrinsically linked to diseases, signs and symptoms, and treatments. Understanding the timeline of clinically relevant events is key to the next generation of translational research where the importance of generalizing over large amounts of data holds the promise of deciphering biomedical puzzles. The goal of our current proposal is to automatically discover temporal relations from clinical free text and structured EHR data and create an aggregated patient-level timeline.